Infrastructure and Opportunity Fund Management

If selected to serve as the lOFM Core, Dr Broide (PI lOFM Core) and the University of California San Diego School of Medicine will ensure that there is timely disbursement, reporting, and monitoring of opportunity funds as part of requested disbursement of funds from the University of California San Diego to other institutions..

Public health relevance
The lOFM Core provides a mechanism to enhance interaction between institutions comprising the AADCRC.